Association Mapping in Structured Populations

[unreadable] DESCRIPTION (provided by applicant): The recent completion of the International Haplotype Map (HapMap) project and the availability of new high-throughput genotyping technologies has ushered in the era of human complex genetic trait genomics. We propose a highly interdisciplinary collaboration among population and quantitative geneticists, statisticians, and molecular anthropologists to identify genes underlying seven heritable traits in 20 African populations. These include: lactase activity, bitter taste perception, height, weight, blood pressure, muscle strength, and handedness. The structure of these populations and the complexity of these traits present a set of challenges for conventional association mapping techniques. The project will involve development of novel algorithms, statistical methodologies, and computational approaches for addressing these challenges as well as data collection and analysis of populations currently underrepresented in complex trait genetics. The project has three major aims. Aim 1: Statistical methods for fine mapping in highly structured human populations. The goal of this aim is to develop robust approaches for identifying the location of genes underlying complex traits when phenotype may have spurious background correlations with genotypes due to ancestry. We will investigate the utility of Hidden Markov Models and Levy processes for solving these problems. Aim 2: Bayesian variable selection methods for graphical models. Many human traits of interest have non-linear environmental and genetic dependencies. We will develop a class of Graphical Models (GM) within a Bayesian variable selection framework that can directly account for these effects. Aim 3: Association mapping of morphological traits in African populations. This aim involves high-throughput genotyping of 1,053 genetically, ethnically, and morphologically diverse individuals of African ancestry studied by Dr. Tishkoff. Nearly all of the DNA for this project has already been collected as part of a previously funded NSF project and a large subset of these individuals have already been phenotyped for lactase activity, bitter taste perception, height, weight, blood pressure, muscle strength, and handedness. We will use the methods developed in Aims 1 and 2 (as well as other approaches) to identify genomic regions and map genes associated with these traits. [unreadable] [unreadable] [unreadable]